The Role of Social, Economic and Environmental Factors in Food Allergy Disparities

PROJECT SUMMARY AND ABSTRACT
Background: Food Allergy (FA) is a potentially life-threatening chronic condition that affects approximately 32
million U.S. children and adults. While an estimated 7.6% of U.S. children have FA, African-American non-
Hispanic children have a significantly elevated risk relative to non-Hispanic white children. Among children
enrolled in the Medicaid program, race and ethnicity were associated with FA such that Asian, Black, and
Pacific Islander/Native Hawaiian children had a higher odd of FA compared with white children. In addition,
racial and income disparities have been observed in the economic burden of FA and in the likelihood of
receiving guideline-based allergy care. Although evidence of disparities is growing, few studies have
examined the source of disparities, especially modifiable factors such as features of the local food
environment, and none have used large administrative data from privately insured children.
Specific Aims and Methods: Theprimary aims of this study are as follows: 1)To measure racial and
ethnic, income, and geographic disparities in FA diagnosis and management among U.S. children, 2) To
assess the contribution of social, economic, and environmental factors to disparities, 3) To identify regional hot
spots of FA diagnosis and management outcomes among U.S. children with food allergy. This study will
leverage two complementary administrative data to examine disparities: the Medicaid and CHIP T-MSIS
Analytic File (TAF) and the Health Care Cost Institute (HCCI) Commercial Claims Research Dataset. The
study population in the TAF will include all children enrolled in the Medicaid program in at least 49 states and
the District of Columbia. The HCCI data will include employer-sponsored insurance claims on approximately 11
million U.S. children ages 0-17 per year. County-level characteristics will be drawn from the University of
Wisconsin Population Health Institute's County Health Rankings & Roadmaps and the USDA's Food
Environment Atlas. The empirical approach will use the framework of racial and ethnic disparity put forth in the
Institute of Medicine's (IOM) 2003 report, Unequal Treatment.
Hypotheses and Expected Results: Our
associating
stores
explain
primary study hypotheses are based on a conceptual model
risky food environments including t hose with high food insecurity and reduced access to grocery
with poorer food allergy management. Specifically, we hypothesize that the food environment will
a statistically significant percentage of the differences in FA diagnosis and management.
Significance and Effects on Other Research: This will be the first study to systematically examine disparities
in FA diagnosis and management among privately and publicly insured children and the first to leverage
existing data to explore the impact of the food environment on disparities. The food environment represents a
potentially modifiable target of intervention to ameliorate disparities in guideline-based allergy care and reduce
unintentional allergic reactions.

Public health relevance
PROJECT NARRATIVE Food allergy (FA) is a potentially life-threatening chronic condition that affects approximately 32 million U.S. children and adults. While an estimated 7.6% of U.S. children have FA, racial and ethnic disparities have been identified. The proposed study will employ methods concordant with the Institute of Medicine's framework for measuring racial and ethnic disparities in health care in order to identify racial and ethnic, income, and geographic disparities in the diagnosis and management of FA among U.S. children and to examine the contribution of county-level social, economic, and environmental factors.